Biochemical Strategy to Avert Microbial Drug Resistance

PROJECT SUMMARY/ABSTRACT
The goal of the proposed research is to develop a generalizable antimicrobial strategy
that averts the onset of resistance. The proposed antiviral agent has a mechanism of
action that relies on the function of a pathogenic protein rather than its inhibition.
Specifically, the agent is a cytotoxic variant of a human enzyme, ribonuclease 1
(RNase 1), that is cloaked and thus inactive as a catalyst. The cloak is removable only by
a pathogenic protease that is essential for the lifecycle of the pathogen. SARS-CoV-2 will
serve as a model pathogen in the study. The goal will be attained by (1) identifying an
optimal amino acid sequence that is cleaved by the 3CLpro protease of SARS-CoV-2 but
not by endogenous human proteases, (2) using that sequence and intein-mediated cis-
splicing to create a cyclic RNase 1 zymogen, and (3) demonstrating the ability of the
zymogen to kill human lung cells that express 3CLpro and that are infected by
SARS-CoV-2. Because the activated zymogen can also destroy the genome of an RNA
virus like SARS-CoV-2, it could eradicate the viral reservoir in patients. A notable feature
of the strategy is its modularity: the protease-cleavage sequence is a cassette that can be
altered to match the specificity of pathogenic proteases for the treatment of other
infectious diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The goal of this project is to derive a generalizable antimicrobial “prodrug” from an endogenous human enzyme. The prodrug will act like a “Trojan Horse” that is activated only in cells that are infected with a pathogenic microbe and cause the death of those cells. The strategy will be developed by using SARS-CoV-2 as a model pathogen.